Developmental Research Project Program

The overarching goals of MT INBRE IV are to 1) maintain and further develop the Montana research network
and student pipeline, and 2) utilize this network to address the serious health disparities that Montana's rural
and Native communities face. To achieve these goals, a key component of MT INBRE IV is to develop
multidisciplinary research capacity across Montana's partner institutions, which include 5 primarily
undergraduate institutions (PUIs), 7 tribal colleges (TCs) and 2 major research universities. Meeting these
goals will be accomplished, in part, through the implementation of the new Developmental Research Project
Program (DRPP), which is an extension of the original Research Core from INBRE I-III. Achieving the DRPP's
goal will lead to a statewide interdisciplinary research network focused on addressing significant health issues
among Montana's rural and tribal communities and strengthening the workforce, research, and student-training
pipeline across MT. Collaborating with MT INBRE IV's Administrative, MT IDeA Community Engagement, and
Bioinformatics and Biostatistics Cores, the DRPP will provide opportunities for investigators across the network
to develop research programs focused on health disparities. Of critical importance in the state's Native
American and rural communities will be projects on resiliency, mental health and suicide prevention, nutrition,
food security/sovereignty, and metabolic diseases. Importantly, the DRPP seeks not only to develop
successful research projects but also to foster their future through a concerted mentoring effort. As such, the
DRPP is invested in the successful career trajectory of the investigators themselves and in the development of
a pipeline of students dedicated to careers in biomedical research. The DRPP will achieve three specific aims.
Aim 1: Continue to develop the established multi-disciplinary health disparities research network to strengthen
biomedical research expertise and infrastructure across Montana and expand its scope and capacity. Specific
Aim 2: Expand the research base and capacity across the MT INBRE network by providing research support to
faculty, postdoctoral fellows, and graduate students. Specific Aim 3: Provide research opportunities for
undergraduate and graduate students that will create a pipeline of students focused on health research
careers.